A MICROPROCESSOR BIOTECHNOLOGY RESOURCE

Continued support is requested for a microprocessor biotechnology resource serving Rockefeller University and the national community through collaborative projects. The program advances biomedical research by integrating state-of-the-art computer science with microprocessor technology to aid biomedical laboratory computing. A major emphasis is to use cooperating multiprocessors to take advantage of the parallelism inherent in concurrent laboratory control, data acquisition and signal processing tasks. The core research includes: a multiprocessor operating system, AMPOS, a multiprocessor architecture featuring hierarchical bus structures and tightly coupled co-processors, each of these projects is in step with the continuing evolution of the hardware technology; a program to develop visually aided, user supportive, interactive, system transferable laboratory software; the utilization of VLSI fabrication techniques to produce light-weight, low power devices for prosthesis and rehabilitation. Collaborative projects (8) include computer applications spanning basic research with data acquisition and signal processing in neurophysiology, cardiology and opiate metabolism, to microprocessor based devices for treating scoliosis and rehabilitating patients with motor-nerve deficits. Representative service projects (7) require maintenance and augmentation of mature systems. Training and dissemination include formal and informal courses, publications and a planned major conference with tutorials.